Improving Microbiome Science by Modeling the Measurement Process

PROJECT SUMMARY/ABSTRACT - Callahan, Benjamin
The Callahan laboratory develops quantitative and computational methods that improve the precision,
accuracy and reproducibility of microbiome measurement methods, and implements those methods in
open-source and actively supported software. The Callahan laboratory collaborates with other research groups
to investigate the role of host-associated microbial communities in various health problems, with particular
emphasis on predicting preterm birth and reducing the spread of antimicrobial resistance.
High throughput methods to measure whole microbial communities without the need for culture have
revolutionized microbiome science. Most prominent amongst a growing suite of “omics” methods are those
based on high-throughput sequencing: amplicon sequencing and metagenomics. However, while these
sequencing-based measurement methods are powerful, they suffer from imperfections and flaws that limit their
application in some sample types and can lead to incorrect conclusions. Over the next five years we intend to
build new capabilities for measuring microbiomes embedded in high-DNA backgrounds by creating new
computational methods for long-read amplicon sequencing. If successful, this will provide microbiome
scientists a measurement method with sub-species resolution that can be inexpensively applied to difficult
sample types like tissue biopsies. We also intend to build new software and methods that correct the bias
inherent in microbiome sequencing measurements. Because different microbial taxa are detected more (or
less) efficiently than others, and this detection efficiency depends on experimental details, the abundances of
microbes measured by sequencing deviate from the true abundances. If successful, our new work will use
measurements of reference materials to correct that deviation and recover the true microbial abundances.
By focusing on proteins (the working molecules of life) rather than DNA (the plans of life), metaproteomics
brings microbiome measurement closer to actual activity and function. Rapid recent advances in mass
spectrometry technology has made metaproteomics more accessible and competitive with sequencing-based
methods, but associated computational and statistical methods are still catching up to these changes. Over the
next five years, we will leverage a new set of reference samples to evaluate metaproteomics measurements
and analysis methods, providing guidance on optimal choices and as needed developing new methods. If
successful, this work will improve the capabilities available to microbiome scientists for studying microbiomes
at the molecular level closest to their function.

Public health relevance
PROJECT NARRATIVE - Callahan, Benjamin The development of modern high-throughput methods that can measure entire microbial communities has changed our understanding of the human microbiome and its effect on our health and well-being, but gaps and shortcomings in these measurement methods remain a major impediment. This research will develop new computational models and methods that will help scientists and health professionals accurately measure microbiomes in the many sites in the human body where they reside. Better measurement of the human microbiome will speed progress towards new diagnostics and treatments for health conditions related to the human microbiome.